ABCD-USA Consortium: Coordinating Center

Abstract Adolescent Brain Cognitive Development (ABCD) is the largest long-term study of brain development and child health in the US. ABCD consists of a Coordinating Center, a Data Analysis and Informatics Resource Center, and 21 research sites. ABCD has enrolled a diverse sample of 11,878 9-10 year-olds, and is tracking their biological and behavioral development through adolescence into young adulthood. All participants receive repeated detailed youth and parent assessments of physical health, mental health, substance use, and culture and environment, and state-of-the-art neuroimaging, neuropsychological testing, and bioassays. In March 2020, when our participants are ages 11-13, the world became substantially affected by the COVID- 19 pandemic, leading to an upheaval in the economy and the lives of almost every family. The majority of US schools closed to reduce viral spread. Many parents incurred changes in work (from home, longer shifts, reduced wages, and/or job loss), some services and support systems became disrupted, and case counts and death tolls surge. The massive multifaceted impact of this unprecedented event has the potential to affect for decades those who are currently children. The proposed research immediately leverages the ABCD cohort, infrastructure, and existing protocol to rapidly characterize the impacts of the COVID-19 pandemic on each child in the study. By collecting this situational information as soon as possible, we can use existing ABCD data to examine perturbations in developmental trajectories of physical health, mental health, substance use, brain functioning, cognition, academic achievement, and social functioning. The proposed project would query all ABCD participants and their parents multiple times about the impact of the pandemic on their lives and, in a subset of participants, examine their physical activity and sleep objectively with activity trackers (Fitbits), over the months of school closures, job loss, and disease spread. This will allow the consortium and scientific community at large to test multiple aims regarding how various facets of the pandemic affect development and outcomes. This includes: (1) characterizing how the COVID-19 pandemic and social distancing efforts impact physical activity, sedentary behavior, screen media use, and sleep; (2) leveraging sensors to objectively evaluate change in physical activity and sleep as youth transition from pre- pandemic to stay-at-home lifestyles; and (3) evaluating the extent to which changes in health behaviors during the stay-at-home period influence long-term health outcomes in youth. This unprecedented crisis provides an opportunity to make use of ABCD’s elaborate infrastructure and rigorous scientific processes to discern critical dimensions of development not previously envisioned.

Public health relevance
Project Narrative Adolescent Brain Cognitive Development (ABCD), the largest longitudinal study of brain development and child health in the United States, follows over 10 years 11,878 children recruited from 21 U.S. research sites, recruited at ages 9-10 in 2016-18. In March 2020, when our participants were ages 11-13, the world became substantially affected by the COVID-19 pandemic, leading to an upheaval in the economy and the lives of almost every family. This project would query all ABCD participants and their parents about the impact of the pandemic on their health and, in a subset of participants, examine their physical activity and sleep with activity trackers, over the months of school closures, job loss, and disease spread.